Nutrition Obesity Research Center

The major goal of the Nutrition Obesity Research Center (NORC) at the University of Washington (UW) is to
support basic, clinical, and translational research at UW related to nutrition, obesity, and related metabolic
disturbances. To achieve this goal, we include three biomedical research cores, an Administrative and
Enrichment Core, and Enrichment and Pilot and Feasibility Programs. Collectively, these Cores and Programs
support research using animal models as well as translational, clinical, and epidemiological research. As the
preeminent educational institution in the Northwest, our research base derives from a large, highly productive,
School of Medicine that includes both clinical and basic research Departments, a School of Public Health, and
affiliated research institutions. We offer a broad range of services to this diverse research base and focus on
three overarching scientific themes: Energy Balance and Obesity Pathogenesis, Health Risks of Obesity, and
Nutritional Aspects of Systemic Illness. Over the years, the organization and offerings of our Cores have evolved
to keep pace with the changing needs of researchers, but always with the same objectives: to support our
investigators, to advance nutrition and obesity-related science, to foster new collaborations, and to educate and
inform the local community about the fields of nutrition and obesity.
The Cores include: 1) an Energy Balance Core, which offers measures of body composition and energy
balance and related endpoints in rodent models; 2) a new Clinical and Translational Research Services Core
which provides Affiliate Investigators (AIs) performing human research with support for study conduct including
human phenotyping, measures of body composition, specialized noninvasive imaging assessment tools, meal
preparation, nutrition assessment, and exercise testing and training; 3) an Analytic Core, which provides AIs with
cost-effective, state-of-the-art laboratory assays for both clinical and basic research, including new assays
designed specifically to meet the evolving needs of our AIs, and includes the Discovery Metabolomics Subcore;
and 4) an Administrative and Enrichment Core that is responsible for all day-to-day operations as well as
administering the Enrichment and Pilot and Feasibility Programs that serve the educational and training needs
of the local research community. The latter Core also contains a Biostatistical Subcore that offers expertise and
support to NORC faculty, personnel, and AIs for study design and biostatistical and bioinformatics analyses
including complex types of high-dimensional data (i.e., omics).
In this way, the NORC helps to meet the evolving research and educational needs of its large and varied
nutrition/obesity research base, which consists of 68 AIs, with collective research funding of $29.2 million in
annual direct costs.

Public health relevance
PROJECT NARRATIVE Obesity and associated metabolic disorders have emerged as leading health problems in the U.S. and, increasingly, globally as well. Both preventing obesity and lowering the health risks of obesity once it occurs, require advancing understanding of its underlying causes. The NORC offers valuable resources to a large group of researchers at UW investigating nutrition, obesity, and associated disorders.